Pilot/Exploratory Studies Component

ASCENT: PILOT AND EXPLORATORY CORE (PILOT) PROJECT SUMMARY/ABSTRACT
In response to the growing population of individuals and families impacted by serious illness and the need for a
national research infrastructure that supports growth of the evidence-base to improve serious illness care, the
Pilot and Exploratory Studies Core (Pilot Core) of the Advancing the Science of Palliative Care Research
Across the Lifespan (ASCENT) Consortium will initiate and support seed projects and their investigative
teams with high potential to advance the science of palliative care across the lifespan. Building the evidence
base for individuals with serious illness and their caregivers across the lifespan is a critical priority. To date, six
National Academies of Sciences, Engineering and Medicine (NASEM) reports and proceedings have
summarized data across multiple settings and diseases that reported the high prevalence and severity of
physical and psychosocial suffering associated with serious illness, including cancer and Alzheimer’s
disease/Alzheimer’s disease related dementias (AD/ADRD). However, the current national infrastructure is
inadequate to fund and support innovative pilot and exploratory projects that generate essential foundational
evidence that can be implemented in practice to address suffering due to serious illness. Serious illnesses,
such as advanced cancer, advanced organ diseases, genetic and developmental disorders, infectious
diseases, multimorbidity, AD/ADRD, and frailty – as well as the associated patient and caregiver suffering – all
fall under the umbrella of palliative care research. To address this need and catalyze growth of research that
will build the evidence base for palliative care, the purpose of the Pilot Core will be to provide funding,
guidance, and support for pilot and exploratory studies that lay the groundwork for larger, more
comprehensive, more groundbreaking studies and trials. The types of studies to be supported by the ASCENT
Pilot Core will include, but are not limited to, the development or piloting of new interventions that have
potential for widescale implementation, exploration of novel methodologies, and initial studies aiming to
understand the mechanisms of effective and accessible palliative care. The specific aims of the Pilot Core are
to: (1) Create and administer an ASCENT Pilot and Exploratory Grants (Pilot) Program to fund palliative
care research projects across the lifespan and a variety of conditions; (2) Foster the growth and
development of early and mid-career investigators with funded awards by providing monitoring,
feedback, and linkages to ASCENT cores and resources; and (3) Promote a national community of
palliative care researchers. The Pilot Core will catalyze the growth of investigators conducting high-quality
research that is likely to result in high-impact research funded by large extramural awards, including awards
focused on cancer and AD/ADRD. Creating a community of researchers aligned in their mission is a key
aspect of the Pilot Core that will benefit and motivate researchers throughout the remainder of their careers.